Training in cancer biology and transplantation

PROJECT SUMMARY / ABSTRACT
The aim of this T32 application “Training in Cancer Biology and Transplantation” is to recruit and prepare
highly qualified and diverse physicians for a research-intensive career in hematology-medical oncology (MO) or
gynecologic oncology (GO). Multiple reports have emphasized the dire shortage of board certified medical and
gynecologic oncologists anticipated in the US in the next decades and the potential impact of these clinical needs
on the pool of physician-scientists to drive the advances in biologically driven, evidence-based care. It is
increasingly important to retain the best and brightest trainees in research careers.
This training program is available only to MD or MD, PhD-prepared applicants who have strong interest
in a research-intensive career. It offers two tracks: 1) support for 2 years of research training for selected
physician/scientists enrolled each year who have completed their first 12 or 18 months of clinical training in our
Accreditation Council for Graduate Medical Education-approved University of Washington/Fred Hutch
Hematology-Oncology Fellowship Program and 2) support for 1 Gynecologic Oncology fellow in our University
of Washington accredited program for 2 years of research training, giving a total of 8 physician-scientist fellows
funded each year. Most of the trainee’s time is spent conducting research under the direct supervision of a faculty
mentor(s) selected by the trainee with additional guidance from a specially selected Research Oversight
Committee and the Executive Committee of the T32.
Our program provides didactic teaching and a strong foundation in research design, develops the
trainees’ ability to conceptualize and solve research problems, encourages increasing independence, provides
training in state-of-the-art analytical techniques, requires trainees to present their research findings at scientific
meetings and publish their results, and conveys an understanding of the relationship of the trainee’s research to
health and disease. Our program consists of 87 talented, well-funded and well-published mentors who are
deployed across five interdisciplinary research pathways to expose trainees to diverse scientific questions,
methodologies, and disease models. Longitudinal evaluation to ensure optimal training for the trainee is intrinsic
to the program. Multiple institutional resources to enhance career development are available to allow all trainees
to develop a customized training plan.
Cancer researchers trained in this program will be exceptional physician-scientists who are prepared for
a career in a research-intensive setting in medical or gynecological oncology, with highly developed research
skills in cancer biology, diagnosis, prevention, therapy, and outcomes. Outcomes are exceptional as
demonstrated by trainee publication rates and entrance into careers as independent researchers in research
intensive positions, our primary metrics for success.

Public health relevance
Cancer is the second leading cause of death in the United States. Its eradication requires trained scientists, especially physician-scientists, to drive the advances in biologically-driven, evidence-based care. The aim of this research training program is to recruit and prepare highly qualified physicians for a research-intensive career in medical or gynecologic oncology by developing research skills in cancer biology, diagnosis, prevention, therapy, and outcomes and to disseminate these advances broadly.